Methocinnamox (MCAM): A novel opioid receptor antagonist

Abstract/Summary
This application requests a supplement to parent cooperative agreement UH3DA048387 and is in response to
PA-20-272 Administrative Supplements to Existing NIH Grants and Cooperative Agreements (Parent Admin
Supp Clinical Trial Optional). The opioid crisis continues despite the availability of FDA-approved medications
for treating opioid use disorder (methadone, buprenorphine, and naltrexone) and opioid overdose (naloxone).
While these medications are effective in many patients, each has pharmacological properties that limit their
clinical utility. Methocinnamox (MCAM) is a novel opioid receptor antagonist with pharmacological properties that
could make it especially useful for treating opioid use disorder (i.e., preventing relapse) and overdose. A single
dose of MCAM blocks the abuse-related and toxic effects of opioids for weeks in rats and nonhuman primates.
MCAM initiatives currently underway at various contract research organizations (CROs) and supported by
UH3DA048387 include the following: 1) good laboratory practice (GLP) in vivo (rats and dogs) and in vitro
toxicology and safety pharmacology studies; 2) chemistry, manufacturing, and controls (CMC); 3) synthesis of
non-GMP MCAM maleate to support the completion of IND-enabling nonclinical studies; 4) stability studies; and
5) development of a clinical plan. A pre-IND meeting with the FDA will occur in Summer 2023. An IND application
will be submitted with the goal of conducting first-in-human studies in 2024. One US patent for MCAM was issued
and three more are under review. The cost of the IND-enabling studies as well as the cost of preparing and
submitting an IND application to the FDA have increased significantly and are much greater than budgeted in
the original application. Due to unanticipated increases in the cost of studies with CROs that are required for the
IND application, there are not sufficient funds in the current award to complete all of the necessary IND-enabling
studies. This supplement requests additional funding to complete synthesis of non-GMP MCAM maleate at
Veranova that will be used to complete the nonclinical toxicology and safety pharmacology studies at Charles
River Laboratories. This program has the potential to significantly impact public health. MCAM has an
exceptionally long duration of action, high oral bioavailability, can be synthesized economically at scale, and
does not have any known adverse effects over a 3000-fold dose range – it has the potential to save lives.

Public health relevance
Project Narrative The continuing opioid crisis underscores the need for more and better medications to prevent relapse and overdose. This supplement to UH3DA048387 requests funding to complete synthesis of the novel opioid receptor antagonist methocinnamox (MCAM) that is needed to complete nonclinical studies necessary for submitting an IND application for MCAM to treat opioid relapse and overdose. Because of its novel pharmacological properties (e.g., exceptionally long duration of action and high oral bioavailability), MCAM has the potential to save lives and reduce the public health burden of the opioid crisis.